HOMEOSTASIS OF ARGININE AND OTHER GUANIDINO COMPOUNDS IN END STAGE RENAL DISEASE

The purpose of this study is to investigate how the body produces and regulates a substance called arginine in patients with severe renal disease.